Community Outreach and Engagement

COMMUNITY OUTREACH & ENGAGEMENT
PROJECT SUMMARY/ABSTRACT
The UC Irvine (UCI) Chao Family Comprehensive Cancer Center (CFCCC) Catchment Area is Orange County
(OC) which represents Region 10 of the California Cancer Registry and in which 70% of CFCCC cancer patients
reside. OC is the third most populous county in California and the sixth most populous county in the U.S. Nearly
two-thirds of county residents are from ethnically-diverse populations and 30% are foreign-born who speak a
total of more than 35 different languages at home. Poverty is higher in these OC populations, as 17% of Latinos,
13% of Vietnamese, 13% of African Americans, 13% of Koreans and 10% of Chinese have incomes below the
federal poverty line, compared to only 5% of non-Hispanic Whites. Geographically, the majority of these diverse
populations reside in central and north parts of OC. UCI is designated by the U.S. Department of Education as
both a Hispanic-Serving Institution and an Asian American/Native American Pacific Islander-Serving Institution,
and we are the sole NCI-designated comprehensive cancer center based in the county.
The mission and long-range goal of the CFCCC's Community Outreach and Engagement (COE) is to reduce
cancer-related burdens in the Catchment Area through cancer monitoring, community outreach and education,
leadership on county coalitions and statewide partnerships including the California Cancer Plan, policy advocacy,
and facilitation of research that promotes cancer health equity within and beyond the Catchment Area. The
Specific Aims of the COE component are: 1) to identify and characterize the cancer burden in OC; 2) to partner
with community leaders and organizations for outreach education; and 3) to facilitate community engagement in
research. COE is led by Associate Director for Cancer Health Disparities & Community Engagement Sora Park
Tanjasiri, DrPH, MPH, a well-established cancer health disparities researcher with deep ties and relationships
throughout OC. The Office of COE is composed of a masters-level Director and two community health educators
who are supported by CFCCC funds under the authority of the Cancer Center Director. These staff engage in
activities covering the continuum of community engagement, including principles of community-based
participatory research, to establish and facilitate partnerships with community-based organizations, clinics, and
public agencies. Guided by both the overall CFCCC strategic plan and a COE-specific strategic plan, COE works
collaboratively with the Community Equity Board to identify cancer education needs and to deliver evidence-
based outreach education to address social, behavioral, and environmental risks within and beyond the
Catchment Area, including the California HPV Vaccination Roundtable and pivoting to address urgent COVID-
19 needs across Southern California. Since its inception, COE has strategically guided the design,
implementation, and dissemination of research studies that reflect UCI's mission to Discover, Teach and Heal,
and the Center's vision to prevent, manage, and cure cancer to promote health and longevity.

Public health relevance
COMMUNITY OUTREACH & EDUCATION PROJECT NARRATIVE Per PAR-20-043, a Project Narrative is not required for this component.